PRC PROJECT THOMPSON

Dynamic Individualized Prediction of Depression Onset Project Dr. Thompson will lead the Dynamic Individualized Prediction of Depression Onset Project. Working closely with Dr. Anderson, Dr. Thompson will develop a Prognostic Bayesian Network (PBN) methodology for applications to preventive outcomes in late life depression. He will implement these methods on existing and ongoing Center-affiliated studies. Dr. Thompson will also develop a freely-available user-friendly software package implementing these methods aimed at late-life depression researchers for use in data analysis and in designing new research studies. He will take the lead in publishing peer-reviewed articles and giving conference talks to publicize this research to a broader audience. Finally, he will work closely with Dr. Anderson in co-directing a graduate student researcher.